TRIBAL TANF-CHILD WELFARE COORDINATION DATA CAPACITY BUILDING

The purpose of this project is to provide guidance and support to Tribal TANF Child Welfare Coordination Grantees that promotes excellence in performance measurement, continuous quality improvement, and grantee-led collaborations between child welfare and TANF agencies in their tribal communities. The project is intended to (1) provide guidance to grantees in revising project logic models to align project activities with intended outcomes; (2) provide support for grantees' identification and collection of performance measures to track project activities and outcomes; (3) provide support to grantees in using data for quality assurance and continuous quality improvement; (4) provide programmatic guidance on ways to strengthen Tribal TANF and Child Welfare coordination in order to strengthen outcomes specified by grantees in their applications; and (5) document these activities and lessons learned. This project will provide universal guidance and peer learning opportunities, as well as grantee specific guidance on a variety of topics which may include identification of measurable goals and objectives, data systems and data privacy, data analysis and interpretation, continuous quality improvement, and dissemination of program successes. The contract was awarded to James Bell Associates.